Center for Demography of Health and Aging

Project Summary
This is a proposal for continuing support of the Center for Demography of Health and Aging (CDHA) at the
University of Wisconsin-Madison. The overall goal of CDHA is to sustain and improve a major research and
training program in the demography of health and aging. The institutional architecture of CDHA is
designed to create links between social demography, economics, biomedical and epidemiological research
on health and aging. Major themes of ongoing and developmental research activities within CDHA include
1) Aging and the Life Course; (2) Biodemography, including data collection and analytical work with
biomarkers, gene-environment interactions and the microbiome; (3) Determinants of sociodemographic
disparities of aging trajectories; (4) Assessing the organization, technology, policy, and delivery of care; and
(5) Place-based impacts on health and aging. CDHA is an autonomous research unit within the College of
Letters and Science where it coexists with the Center for Demography and Ecology. It thus shares and
extends a well-developed research infrastructure in administration, computing facilities and data library,
and dissemination capacity. CDHA’s Administrative Core (A) provides leadership and administrative
support for the Center as a whole, particularly for activities of Core B. The Program Development Core (B)
supports faculty, staff, and research assistants engaged in innovative, high-risk pilot research projects that
are likely to lead to major NIA support. The External Innovative Network Core (C) will continue a highly
successful and popular, networked current awareness service for research in the demography of health and
aging and support regular workshops, conferences, and visits. The External Research Resources Core (D)
supports the analysis of large-scale public and restricted-use data resources in the demography of health
and aging and disseminates important research findings. The Remote Data Enclave (E) supports the
analysis of sensitive data under secure conditions and integrates with a state-of-the art Federal Statistical
Research Data Center facility on the UW-Madison campus.

Public health relevance
Project Narrative Individual aging is the outcome of biological configuration and socioeconomic conditions and experiences. Aggregate population aging alters individual aging as it generates conditions that affect social organization, health services, and macro-economic change. CDHA helps to investigate these issues as an innovative and flexible provider of research products, training, and infrastructure for sharing scientific insights.